Discovery of Molecular Probes and Therapeutic Leads: Upgrade of an Electron Paramagnetic Resonance Spectrometer

ABSTRACT: An administrative supplement is requested to purchase Bruker E500 CW
Electron Paramagnetic Resonance (EPR) spectrometer to support P20 GM104316:
Discovery of Chemical Probes and Therapeutic Leads. The goal of this COBRE is to
continue our efforts to develop molecular approaches for probing biology, to discover
and apply new chemical biology tools for the study of biological pathways associated
with disease, and to develop computational approaches for understanding small
molecule interactions with complex macromolecular targets. The goal of this
administrative supplement is to request funds for the upgrade of a Bruker E500 CW
Electron Paramagnetic Resonance (EPR) spectrometer with both X-band and Q-band
capabilities. The upgrade will support purchase of a Microwave Bridge Controller, Digital
Ultra High Resolution Hall Field Controller, and Dual Channel Signal Processing Unit
(SPU) and a SuperX selected ultra low noise CW X-band microwave bridge. The
spectrometer will interface with our existing magnet, Q-band bridge and our existing He
VT-unit. The upgrade will replace an old EMX-EPR instrument that has been non-
functional for more than 10 years. Currently, there is no functioning EPR instrument on
the UD campus. The availability of EPR will support current COBRE researchers and
will be important for the recruitment of new faculty to the UD campus in COBRE-related
research areas.

Public health relevance
Project Narrative This center of Biomedical Research Excellence is a multidisciplinary center that using synthesis, chemical biology and computation to develop molecular approaches for understanding and treating human disease, with a focus on infectious diseases and cancer.